Impact of Vitamin D on the Chemopreventive Efficacy of Erlotinib against Oral Cancer

Project Summary The outbreak of COVID-19 has changed the practice of medicine in a fundamental manner resulting in sweeping changes in healthcare virtually across all medical specialties. Dentistry, in particular, has been dramatically affected by this pandemic, given the close `person-to-person' contact involved in delivering dental care and treatment procedures that produce aerosols and often result in the dental health care professional (DHCP) contact/exposure to blood, saliva and respiratory droplets. Specifically, the pandemic has led to adaptations to diagnostic and treatment paradigms, modifications to clinical workflow and dental/oral care delivery models. Given that the pandemic is still on-going, the magnitude of the impact of these modified oral health care delivery models, especially in high-risk patient populations (e.g. cancer patients) is not known. This application for a “Urgent Competitive Revision to Existing NIH Grants (Urgent Supplement)” is being submitted in response to PA-18-935 to request supplemental funding to the R01DE024595 (PI: Seshadri, Mukund). The research proposed in this supplement was specifically developed in response to the recent coronavirus disease 2019 (COVID-19) pandemic to assess the impact of dental care delivery delays in cancer patients. The proposal is of immediate and high impact to NIDCR.

Public health relevance
Project Narrative This application for a “Urgent Competitive Revision to Existing NIH Grants (Urgent Supplement)” is being submitted in response to PA-18-935 to request supplemental funding to the R01DE024595 (PI: Seshadri, Mukund). The research proposed in this supplement was specifically developed in response to the recent coronavirus disease 2019 (COVID-19) pandemic to assess the impact of dental care delivery delays in cancer patients.